Mindfulness-Based Relapse Prevention as Video Conferencing Continuing Care to Promote Long Term Recovery from Alcohol Use Disorder

PROJECT SUMMARY
Alcohol use disorder (AUD) is prevalent and costly, and associated with significant morbidity and mortality.
Effective pharmacological and psychosocial treatments for AUD exist, although many individuals do not
receive medications and most are treated via mutual support group participation. Alcoholics Anonymous and
other mutual support programs have been shown to be highly effective in supporting abstinence, and they are
a tremendously valuable option for those interested in abstinence-based recovery. Yet, approximately 80% of
individuals with AUD never seek treatment and not wanting to stop drinking is a common barrier to seeking
treatment. AA and other mutual support programs are often abstinence-based, yet programs that focus on
reductions in drinking have been shown to be as effective at reducing harms related to alcohol use. Recent
studies in population-based and clinical samples indicate significant health benefit from drinking reductions,
without total abstinence. Aligned with these findings, the National Institute on Alcohol Abuse and Alcoholism
has proposed a new operational definition of recovery defined as: remission from AUD, cessation of heavy
drinking, and improvements in functioning and well-being. Expanding the definition of recovery to include non-
abstinent outcomes could increase treatment seeking among those with AUD who are not willing to abstain but
are willing to reduce drinking, and reduce the public health burden of untreated AUD. One program that has
considerable promise for promoting AUD recovery is mindfulness-based relapse prevention (MBRP). Efficacy
of MBRP for reducing heavy drinking has been shown in several trials. Further, MBRP explicitly targets
neurobiologically-informed domains of addiction: inhibitory control over behavioral responses (executive
function); craving and cue reactivity (incentive salience); and negative affect (negative emotionality). MBRP
may also be more effective than existing continuing care options in targeting broader health and life
functioning. MBRP also has the potential to be broadly accessible via video conferencing. The goal of this
study is to examine the effectiveness of MBRP groups delivered via video conferencing in promoting whole-
person recovery from AUD up to three years following an attempt to change or stop drinking via treatment or
self-change, as compared to referral to online mutual support groups. This study will also examine how MBRP
affects mechanisms of behavior change based on neurobiologically-informed addiction cycle domains. We will
use an effectiveness-implementation design to prospectively test the effectiveness of MBRP, as well as identify
barriers and facilitators of MBRP group participation to inform future implementation of MBRP continuing care.
The ultimate goal of this work is to evaluate MBRP via video conferencing as a continuing care option that
supports whole-person recovery and targets addiction cycle domains in supporting long-term recovery from
AUD in communities nationwide, including a focus on underserved areas. Availability of effective, evidence-
based continuing care interventions may reduce the public health burden of AUD.

Public health relevance
NARRATIVE To address the public health burden of alcohol use disorder (AUD), there is a tremendous need for continuing care options to support long-term recovery from AUD that (1) support whole-person recovery, defined as focusing on both functioning and reductions in drinking or abstinence, (2) are effective in targeting the neuroadaptations observed among those with addiction, and (3) are accessible in all communities nationwide, including medically underserved and health professional shortage areas. This project will evaluate the effectiveness and mechanisms of mindfulness-based relapse prevention (MBRP) delivered via video conferencing, as compared to referral to online mutual support groups, in supporting long-term whole-person recovery and improvements in neurobiologically-informed domains of addiction among individuals with AUD who have recently made a change attempt to reduce or stop drinking. The project will also examine the reach, effectiveness, adoption, implementation, and maintenance of MBRP as an accessible and freely available continuing care option that supports long-term recovery from AUD in all communities nationwide, including medically underserved and health professional shortage areas.